A Positive Psychology Intervention for Irritable Bowel Syndrome

PROJECT SUMMARY/ABSTRACT
Irritable bowel syndrome (IBS) is a disorder of gut-brain interaction (DGBI) that affects up to 39 million U.S.
adults and is associated with substantial psychiatric comorbidity, healthcare costs, and impaired health-related
quality of life. Conceptualized as a biopsychosocial stress-sensitive disorder, treatment of IBS often includes
the use of behavioral interventions. Existing behavioral interventions for IBS, however, face important
limitations, including reduced scalability, low acceptability, limited mechanistic understanding, and limited
attention to the promotion of positive psychological constructs (e.g., resilience), which are deficient in patients
with IBS and independently linked to fewer IBS symptoms and superior health outcomes. Positive
psychological interventions (PPIs), comprised of simple-to-perform exercises (e.g., using perseverance), have
potential to improve IBS symptoms and address the limitations of existing interventions, but, aside from our
preliminary work, have not previously been explored in IBS. This 5-year K23 Patient-Oriented Research Career
Development award addresses this research gap by: (1) examining the feasibility, acceptability, and
preliminary efficacy of an optimized 9-week phone-based PPI for IBS, entitled, “WISH,” compared to a time-
and attention-matched educational control in a pilot NIH Stage 1B randomized controlled trial (N=50); (2)
exploring candidate gut-brain mechanisms (i.e., changes in autonomic function, interoception, and stress-
mediated gene expression) by which WISH might impact IBS symptoms; and (3) identifying potential
facilitators and barriers to implementation of WISH and other behavioral interventions in diverse
gastroenterology (GI) clinical practice settings. This innovative project represents the first examination of a PPI
for IBS as well as exploration of its potential gut-brain mechanisms, and, consistent with the NIH stage model,
incorporates implementation science principles early in behavioral treatment development. The corresponding
training plan will support Dr. Elizabeth Madva in becoming an independent GI psychiatrist-investigator and
developer of scalable, well-accepted, and mechanistically targeted behavioral interventions, from pilot testing
to implementation, for individuals with DGBI. Training in three key areas will support Dr. Madva’s transition to
research independence: (1) clinical trial design, control condition development, and related biostatistical
analyses to evaluate behavioral interventions for DGBI; (2) the study of gut-brain mechanisms of behavioral
interventions; and (3) implementation science. A multidisciplinary mentorship team with complementary
expertise will oversee Dr. Madva’s training: Dr. Jeff Huffman (primary mentor); Drs. Braden Kuo, Laurie Keefer,
and Stephen Bartels (co-mentors); and Drs. Brian Healy, Roberta Sclocco, Sami Amr, and Christopher Celano
(significant contributors). The proposed project and training will inform preparation of an R01 application to
conduct an NIH Stage 2 efficacy trial to examine the true efficacy and mechanisms of this novel PPI for IBS.

Public health relevance
PROJECT NARRATIVE Positive psychological (PP) constructs (e.g., positive affect, resilience) are deficient in patients with irritable bowel syndrome (IBS) and independently linked with fewer IBS symptoms and superior health outcomes, but interventions to promote these constructs (i.e., PP interventions), which have shown promise in other populations, have not previously been explored in IBS. The proposed study aims to evaluate the feasibility, acceptability, preliminary efficacy, and candidate gut-brain mechanisms of a novel 9-week, phone-based PP intervention customized for IBS, as well as to consider potential facilitators and barriers to implementation of this and other behavioral interventions in diverse gastroenterology clinical practice settings. If effective, this novel PP intervention for IBS has the potential to improve IBS symptoms, health-related quality of life, and well-being for individuals with this complex and high-comorbidity condition.